BCCMA: Targeting Osteoarthritis Pain and Progression: Defining biologic and inflammatory markers associated with rapid progression

1 Knee osteoarthritis (OA) is a leading cause of disability worldwide. Disease development in
2 Veterans occurs at significantly younger ages and at higher numbers than the population in
3 general. Currently there are no disease modifying anti-osteoarthritis drugs (DMOAD) due in part
4 to a historical focus on identification and tracking of radiographic OA outcomes rather than
5 cellular and molecular disease pathways in pre-radiographic OA. The TOPP Collaborative Merit
6 Review will test the central hypothesis that heterogeneity in OA pain and structural progression
7 is related to the “immune pathotype” of OA, which arises from the variability in the cellular and
8 molecular responses of bone, cartilage, and synovium to inflammation and joint mechanical
9 environment. The overarching Specific Aims are: Aim 1: To improve understanding of
10 osteoarthritis (OA) pathogenesis to enable development of targeted early treatment
11 approaches; and Aim 2: To establish preclinical and clinical data for new therapeutic targets to
12 reduce pain and prevent OA progression. Achieving these Aims requires the complementary
13 and synergistic expertise of our Collaborative Merit to employ early and late OA clinical cohorts
14 prevalent in the VAHCS and joint injury animal models to define the immune pathotypes of OA
15 and to test novel therapeutic approaches. This particular project will establish a cohort of
16 patients without significant signs of radiographic OA who suffer from symptomatic degenerative
17 meniscus tears (DMT) to identify predictors of pain and progression after arthroscopic partial
18 meniscectomy (APM). Degenerative meniscus tears (DMT) are prevalent starting in middle age
19 and can occur in the absence of significant radiographic knee OA. Growing evidence also
20 suggests that the DMT may signal transition of the knee to an OA phenotype. Similar to OA
21 treatment, clinical outcomes for DMT patients have been reported to be highly variable
22 irrespective of whether treatment is with physical therapy, APM, or sham surgery. We
23 hypothesize that the variable results following APM treatment of DMT are related to whether
24 joint biology has switched to an OA phenotype. This project aims to test this hypothesis by
25 identifying biological predictors of knee pain and structural progression in Veterans 2 years after
26 treatment of symptomatic DMT with APM. Aim 1 of this study will test if preoperative synovial
27 fluid levels of OA biomarkers supported by our preliminary data and prior work (C2C, C1,2C,
28 COMP and CS846) predict knee pain and structural progression in DMT patients 2 years
29 following APM. Aim 2 will test if preoperative serum biological markers implicated in OA pain by
30 our preliminary data (IL-4, IL-13, and IL-17E) predict knee pain and structural progression 2
31 years after APM. Aim 3 will test if preoperative levels of urine uCTXII and uCTXIIa predict knee
32 pain and structural progression in our DMT cohort 2 years after APM. Achieving the Aims of this
33 proposal will contribute new information important to defining immune pathotypes and
34 biomarkers of early human OA. Completing this project will also help determine whether DMT
35 patients with biological signatures of OA comprise a novel early OA cohort prevalent within the
36 VAHCS suitable for clinical trials evaluating new treatment strategies to prevent or delay the
37 onset of disabling OA. These outcomes support the overarching hypothesis and Aims of the
38 TOPP Collaborative Merit Review and have high potential to improve the care of the large
39 number of Veterans and members of the general public who suffer from knee OA.

Public health relevance
Knee osteoarthritis (OA) is a leading cause of premature disability and a substantial public health burden that is disproportionately borne by Veterans. There are no drugs to halt or reverse advanced OA. Thus, treatment of earlier OA is needed. The Targeting Osteoarthritis Pain and Progression (TOPP) Collaborative Merit Review aims to establish necessary preclinical and clinical information to improve understanding of how OA develops and to identify new treatments for different types and stages of OA. The degenerative meniscus tear (DMT) might be an early sign of knee OA. This means some DMT patients may already have biological knee OA even though their Xrays don’t yet show OA. This particular research project will examine if certain proteins in joint fluid, blood and urine predict whether pain and OA become better or worse after arthroscopic partial meniscectomy (APM). It will also contribute critical information and biospecimens for use in the TOPP collaboration so better treatments can be developed to help Veterans and others with knee OA.